Administrative Core

PROJECT ABSTRACT – ADMINISTRATIVE (ADMIN) CORE
The Admin Core, led by Co-Directors Drs. Nichols and Bae-Jump, will serve as the central coordination hub for
the Cancer Health Disparities SPORE in Endometrial Cancer investigators and staff, with responsibility for
monitoring the progress of all Projects, Cores, and Programs towards translational/ clinical endpoints and guiding
future strategic directions. The Core will ensure compliance with all university, federal and specific NIH grant
regulations and requirements, including timeline communications and consultation with the National Cancer
Institute. It will facilitate meetings and interactions with all SPORE investigators, personnel, members of the
advisory boards, and collaborators internal and external to the University of North Carolina at Chapel Hill.
Leadership meetings will be weekly, Executive Committee meetings biweekly, Community Advisory Board
meetings quarterly, and Internal and External Advisory Boards will meet annually. The Admin Core will also
contribute to the organization of two statewide symposia developed by the COE Core. The Admin Core will
provide oversight to the Career Enhancement and Developmental Research Programs. These functions will
assist the SPORE leadership in ongoing planning and evaluation of SPORE activities to ensure successful
completion of the proposed aims and resolution of any scientific or administrative challenges that may arise. The
Admin Core will have overall fiscal responsibility for the SPORE to ensure cost-effective and strategic use of
resources, including the substantial institutional commitment ($2.5 million) to projects, infrastructure, career
enhancement and developmental research programs. Through these activities, the SPORE Administrative Core
supports an exceptional team of translational basic science, clinical and population science researchers working
to eliminate disparities in endometrial cancer.
1